Machine learning methods to assess risk for prenatal and neonatal iron deficiency anemia from maternal stress exposure

This project aims to determine biological and behavioral pathways by which maternal psychosocial stress in pregnancy impacts risk for maternal and infant iron deficiency anemia (IDA). IDA is one of the most common causes of anemia worldwide, and around 20% of women in the US experience a stressful life event throughout their pregnancy. Due to the increased iron demands of pregnancy, pregnancy itself poses a significant risk of IDA. IDA increases the risk of adverse pregnancy outcomes and can negatively impact the iron status of the neonate that may cause irreversible harm to neurodevelopment. There is growing concern that oral vitamin supplementation might not be enough to counteract the risks of IDA in the context of systemic inflammation, including inflammation produced by chronic psychosocial stress and subsequent neuroendocrine dysregulation. Maternal psychosocial stress has been associated with infant iron status previously, but the potential biological mechanisms are not yet characterized despite the

Public health relevance
public health relevance. This study fills a critical gap by addressing the effects of maternal non-infectious chronic psychosocial stress and HPA axis functioning on maternal and fetal iron status. The study aims to determine stress-induced inflammatory and hepcidin-mediated mechanisms underlying the association between chronic maternal prenatal stress and risk for maternal and offspring IDA. Aim 1A and 1B will use supervised machine learning to examine whether maternal chronic stress exposure and cortisol phenotypes relate to hepcidin in pregnancy and whether this pathway is mediated through maternal inflammation. These methods will also characterize which maternal chronic stress exposure and cortisol phenotypes in pregnancy predict maternal iron status in the third trimester and test whether maternal inflammation and hepcidin in pregnancy mediates the associations. Aim 1C will apply similarity network fusion to predict offspring iron status in cord blood at birth from networks of maternal stress, inflammation, hepcidin, and maternal iron status across pregnancy. This study will identify inflammatory-driven hepcidin mechanisms between maternal psychosocial stress, neuroendocrine dysregulation, and risk for IDA in mother and offspring in a prospective pregnancy cohort. The proposed project will help to identify outcome-specific mechanisms and markers alongside possible modifiable factors as future targets for intervention. Data yielded from the proposed studies will lead to a future research program examining maternal stress, IDA risk, and offspring neurodevelopment longitudinally within a developmental origins of health and disease framework. This approach will elucidate neuroendocrine mechanisms relevant to maternal and child outcomes, inflammatory markers of child IDA risk, and modifiable risk factors to support optimal maternal and fetal health.